RSK3 Anchoring Disruptor Therapy for Heart Failure

Novel therapeutic approaches are desperately needed in an expanding patient population to improve
both the survival and quality of life for patients with or susceptible to heart failure. Research over the last two
decades has established p90 ribosomal S6 kinase type 3 (RSK3) as a pivotal regulator of pathological cardiac
remodeling, including in mouse models of pressure overload and genetic cardiomyopathy. RSK3 is required for
pathological remodeling even though RSK3 is less abundant in the cardiac myocyte than other members of the
RSK protein kinase family. The efficiency and specificity of intracellular signal transduction can be enhanced by
the anchoring and co-localization of key enzymes and their upstream activators and substrate effectors by
scaffold proteins. RSK3’s unique N-terminal domain confers high affinity binding to the scaffold protein muscle
A-kinase anchoring protein β (mAKAPβ) in the cardiac myocyte. Recently published data show that blockade of
RSK3 association with mAKAPβ by adeno-associated virus (AAV) mediated expression of the mAKAPβ-derived
RSK3 Binding Domain (RBD) anchoring disruptor polypeptide will inhibit the development of pathological
remodeling and heart failure during chronic pressure overload in the mouse. Newer data demonstrate that RBD
expression will also prevent remodeling following myocardial infarction (MI) in the mouse. Cardiac RSK3
Inhibitors, LLC (CRI Biotech) is a company developing patent-protected therapeutics targeting cardiac myocyte
mAKAPβ signalosomes for the prevention and/or treatment of heart failure. To target mAKAPβ-RSK3-dependent
signaling via blockade of the mAKAPβ-RSK3 protein-protein interaction, CRI Biotech proposes to treat patients
at risk for heart failure with the new self-complementary, serotype 9 AAV gene therapy vector AAV9sc.RBD. As
a dose sufficient to deliver AAV9sc.RBD with high penetrance to the swine myocardium has been determined,
CRI Biotech will now test in this Direct to Phase II SBIR project the efficacy of AAV9sc.RBD in a clinically relevant
swine model of ischemic cardiomyopathy. Specific Aim 1: Efficacy of RSK3 anchoring disruptor peptide for
post-myocardial infarction heart failure in a large animal model. The core of this project is to test whether
RBD peptide expression will reduce pathological remodeling induced by MI in swine, preventing heart failure.
Swine will be subjected to ischemia-reperfusion injury to induce MI and then treated immediately afterwards with
AAV9sc.RBD by antegrade intracoronary infusion. Cardiac function will be assessed serially for 12 weeks post-
MI. Specific Aim 2: AAV9sc.RBD-mediated inhibition of the molecular and cellular pathology associated
with heart failure. Taking advantage of tissue collected from the same animals used in Specific Aim 1, the
benefits of the RBD anchoring disruptor biologic in swine will be further demonstrated by gravimetric, histological,
and molecular analyses for fibrosis and other markers of cardiac remodeling and heart failure. In addition, initial
toxicology screens will be done to test AAV9sc.RBD safety.

Public health relevance
Heart failure is a syndrome of major public health significance that contributes to the death of about 1 in 8 Americans. Despite a range of existing therapies, the mortality rate for patients with heart failure is high, with nearly 50% of patients dying within 5 years of a diagnosis. In this application, we aim to develop a new therapy for heart failure based upon selectively targeting the anchoring of RSK3 to the scaffold protein mAKAPβ.